From Lab to Labor: Advancing Diabetes Pregnancy Care

Abstract
The global rise in obesity and Type 2 diabetes has led to an increase in pregestational diabetes, significantly
raising risks during pregnancy. Uncontrolled hyperglycemia is teratogenic, resulting in adverse maternal and
fetal outcomes, with "diabesity" being a critical area of focus for the Diabetes in Pregnancy Study Group of
North America (DPSG-NA). Since its inception in 1997, DPSG-NA has aimed to improve pregnancy outcomes
in diabetes by advancing research, shaping medical policies, and influencing professional practices.
The biennial DPSG-NA meetings have driven research progress, addressing controversies in GDM screening,
diagnosis, and treatment, and have evolved to include discussions on congenital malformations, perinatal
mortality, and cost-effective diabetes management. The 18th biennial meeting in 2025, titled "From Lab to
Labor: Advancing Diabetes Pregnancy Care," will emphasize nutrition in pregnancy and aim to support early-
stage investigators (ESIs) in the field. Key objectives of the meeting include: 1) supporting ESIs through
planning and networking opportunities, exposing ESIs to groundbreaking work, fostering new projects and
addressing knowledge gaps in diabetes and pregnancy research, 2) presenting of the latest research in
diabetes and nutrition in pregnancy by well-established investigators, facilitating knowledge exchange and
fostering collaboration among early-career and experienced investigators, and 3) disseminating findings,
especially to practitioners treating underserved populations, ensuring a comprehensive understanding of
challenges and solutions in managing diabetes in diverse populations. Efforts to encourage participation from
underserved regions will enhance the scope of discussions, while collaborative research presentations and
abstract submissions will stimulate further advancements in the field. The meeting's outcomes will be shared
through peer-reviewed publications, contributing to a robust research community focused on improving
outcomes for pregnancies complicated by diabetes.

Public health relevance
Project narrative: The primary objective of the 18th Biennial Meeting of the Diabetes in Pregnancy Study Group North America (DPSG-NA), titled “From Lab to Labor: Advancing Diabetes Pregnancy Care,” is to provide a forum for discussion regarding innovative research aimed at improving the prevention, management, and treatment of gestational diabetes, pregestational diabetes, and nutritional considerations during pregnancy. This event seeks to bring together investigators and clinicians to cultivate knowledge exchange and collaboration. These discussions will provide networking opportunities for early-stage investigators. Sessions focus on a combination of classically discussed diabetes topics as well as innovative technologies and artificial intelligence.